Neural Response to Risky Decision Making in Youth at High Risk for Substance Use Disorders and HIV

PROJECT SUMMARY The intern working with our team will become immersed in a pediatric neuroimaging risk study which is currently in the data collection and data analysis phases. We will begin with human subjects training and then allow the intern to observe all aspects of the study including subject recruitment, data acquisition, instrument scoring, data cleaning and data analysis. We will then determine which aspect of the study is of greatest interest to the intern and work to create a discrete project that they can accomplish, with study team assistance. Ideally this will either be a contribution to a manuscript or a poster in the area of mechanisms underlying risky decision making. We will also encourage the intern to shadow Dr. Hulvershorn in the adolescent addiction clinical program to see the translational relevance of the work.

Public health relevance
PROJECT NARRATIVE Difficulties with decision-making, particularly in risky situations, may place some youth at high risk for the development of substance use disorders and risky sexual practices. This project investigates brain mechanisms in high and typical risk youth that underlie decision-making, prior to the effects of drug use on their brain. Youth will be followed over several years to determine if brain activation associated with decision- making predicts the onset of risky drug use and sex and lays the foundation for the development of interventions focused on improving decision-making.